Monoaminergic and limbic systems underlying narcolepsy-cataplexy

Project Summary/Abstract:
Regulation of sleep and arousal states is delicately balanced by a network of distinct brain regions. In
patients with narcolepsy, this balance is disrupted, leading to excessive daytime sleepiness, and disrupted
nighttime sleep. Patients with narcolepsy also experience cataplexy: abrupt muscle atonia during waking, often
in response to strong, positive emotions. Despite significant research efforts, it remains unclear what
mechanisms functionally regulate cataplexy. Muscle atonia is regulated by brainstem regions such as the
ventrolateral periaqueductal gray and adjacent lateral pontine tegmentum (vlPAG-LPT), which is directly
innervated by neurons in the limbic system, including the nucleus accumbens (NAc) and central nucleus of the
amygdala (CeA). The NAc and CeA mediate responses to positively valenced stimuli and are densely
innervated by the dopamine system, while the vlPAG-LPT is innervated by neurons in the locus coeruleus, the
primary source of norepinephrine in the brain.
The goal of this proposal is to clarify how monoaminergic systems and limbic-brainstem projections
promote cataplexy and disrupted sleep in narcolepsy. First, we will characterize the precise temporal dynamics
of dopamine release in the NAc during cataplexy and changes in state, as well as determine if stimulating
dopamine release in the NAc is sufficient to drive cataplexy. Next, we will identify the release dynamics of
norepinephrine in the vlPAG-LPT and determine if increasing noradrenergic tone in the brainstem is sufficient
to alleviate cataplexy propensity. Finally, to elucidate the functional connectivity between the limbic system and
muscle atonia-generating regions, we will record and manipulate neurons in the NAc and CeA that project to
the vlPAG-LPT to evaluate if these projections regulate muscle atonia. We will use a combination of in vivo
fiber photometry and fluorescence-based monoaminergic sensors, Ca2+ recording, circuit-specific opto- and
chemogenetics, and chronic recording of EEG/EMG in freely moving animals to investigate these circuits.
The proposed research is significant as it will meaningfully contribute to our understanding of the
circuitry underlying narcolepsy symptoms, regulation of arousal states, and establish a relationship between
emotional processing and muscle tone. The proposed research is also innovative as it will utilize state-of-the-
art, multidisciplinary approaches to define the neural underpinnings through which monoaminergic and limbic
systems act to mediate muscle atonia and disrupted sleep. Collectively, this information will significantly
improve our understanding of REM sleep circuitry and narcolepsy, leading to development of more effective
treatments of narcolepsy and other disorders resulting in disrupted sleep and abnormal motor control across
states, such as REM-sleep behavior disorder and obstructive sleep apnea.

Public health relevance
Project Narrative: The proposed research is relevant to public health because narcolepsy, a REM sleep-related disorder, affects 1 in 2000 individuals in the US and there are significant health and financial costs associated with this disease. Understanding the neural mechanisms that underlie narcolepsy, particularly how monoaminergic and limbic systems contribute to excessive sleepiness and abnormal motor control across states, is necessary to identify new targets and approaches to treating narcolepsy, as well as sleep disorders more broadly. Thus, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental basic science discoveries, using innovative approaches, with the goal of ultimately improving health.